NASAL CALCITONIN IN THE PREVENTION OF OSTEOPOROSIS

The purpose of this study is to determine the efficacy of different doses of calcitonin nasal spray in the prevention of early postmenopausal bone loss, in normal women. This is a prospective, randomized, placebo-controlled trial over two years.